SPINAL ANESTHESIA FOR POST-PARTUM TUBAL LIGATION:

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The aims of this study are to compare the anesthesia effects, side effects, length of analgesia and incidence of transient radicular irritation [pain in buttocks, thighs, and legs] of intrathecal [into the spinal canal] demerol and intrathecal lidocaine after a post partum tubal ligation.